A systematic approach to enhance extremity protection in Alaska fishing industry

PROJECT SUMMARY
Each year, thousands of workers in the farming, fishing, and forestry sectors suffer hand injuries and illnesses causing
significant healthcare costs and loss of productivity. Fishery workers are often exposed to cold temperatures, high wind
velocities, and wet weather while handling cold/frozen equipment/objects. This can cause blood vessels to constrict,
reducing blood flow to extremities and decreasing hand dexterity and tactility, which in turn increases the risks of traumatic
hand injuries and exacerbates musculoskeletal disorders. However, the underlying mechanisms and fundamental parameters
that affect blood circulation and skin temperature of a hand holding a fishing tool while wearing a protective glove and
being exposed to extremely cold and wet conditions is still largely unknown. This knowledge-gap and absence of relevant
industry standards has forced fishery workers to use gloves designed for other purposes and occupations, usually where the
focus is purely mechanical protection (tears, cuts, punctures, etc.) while neglecting thermoregulatory aspects. These gloves
are inadequate for fishery work due to poor thermal and moisture management, causing thermal discomfort and reduced
dexterity and grip, thereby contributing to hand injury in the worst-case scenario. This project aims to reduce hand injuries
in the fishing industry by establishing a framework to provide scientific directions for the development of standards,
regulation, evaluation methods, and selection guidance of existing and next generation protective gloves through an
interdisciplinary exploration-examination-prediction approach. We will develop and validate a 3D multi-segment hand
thermoregulation model capable of simulating the thermophysiological response of fishery workers exposed to cold and wet
conditions, repetitive motion, and fast-paced hand activity. The expected results will elucidate how ambient conditions,
gloves, and tool gripping interact to affect blood flow and skin temperature in each hand segment, thus providing new
insights for the design and development of effective fishing gloves that consider hand thermal physiology and optimize
hand function while accounting for the particular usage environment and fishing tasks. This project has three specific aims:
(1) market and usage experience analysis and performance evaluation of existing protective gloves, (2) developing a 3D
multi-segment hand-specific thermoregulation model for fishery workers, and (3) using model simulations to investigate
the impacts of glove material properties, environmental factors, and hand posture (fishing activities) on the
thermophysiological response of the hand. The proposed work is innovative because it departs from the status quo by
employing a synergistic and convergent approach to develop and evaluate hand protective gear that will lead to new designs
and materials that account for the human thermophysiological response and ergonomic factors to mitigate the risk of hand
injuries. Finally, the expected outcomes have significant potential to guide new material development and apply functional
and ergonomic designs, and generate new evaluation standards and usage guidance for gloves to achieve balanced protection,
comfort, and performance.

Public health relevance
PROJECT NARRATIVE Fishery workers suffer significant hand and finger injuries due to exposure to cold, wet environments and repetitive impact forces that adversely impact hand thermophysiological responses and functions. This project will evaluate existing protective gloves performance and develop a modeling tool to investigate the synergistic effects of thermoregulatory, ergonomic, and environmental factors on hand thermophysiological responses. Such a model is a critical step towards establishing fishing industry hand protection regulations and developing effective protective gloves that reduce the prevalence of hand injuries.